Overcoming pressure ulcers with engineered hormones and stem cells

Abstract
Pressure ulcers (PUs) are a common and painful health condition, particularly among people who are elderly or
physically impaired. PUs can affect at least 3 million adults in the U.S. and lead to more than 60,000 patients
with PUs dying from these ulcers each year. Poor tissue regeneration causes substantial morbidity and is the
most crucial risk factor for specific extremity amputation. Primarily, peripheral neuropathy and endothelial
dysfunctions attribute to PUs. There is lacking regimens that effectively enhance tissue regeneration in pressure-
damaged tissue regeneration patients. Many patients still face limb amputation and increased mortality. There
is an unmet yet urgent medical need to develop novel regimens to enhance pressure-ulcer healing and prevent
the recurrence of PU injury healing. We propose this research to tackle this poorly addressed problem. To
overcome this obstacle, we have developed a group of “novel hormonal therapeutics,” stable chimeric albumin
(Alb)- or IgG Fc (Fc)-hormones fusions (Alb- or Fc-hormones) biologics and stable hormones-based
nanomedicines. These engineered stable fusions of biologics or nanomedicines will exhibit prolonged bioactivity
and efficacy in vivo compared with wild-type hormones. These stable analogs may hold promise for treating
pressure ulcers themselves. However, we reason that highly durable hormonal fusion biologics or slow-release
formulas for nanomedicines (i.e., hormonal therapeutics) will be essential for clinical success because pressure
ulcers usually require extended treatments. Our nontoxic hormonal therapeutics will also reduce potential
systemic side effects. Based on this understanding, we hypothesize that delivering highly durable Alb- or Fc-
hormone fusion biologics (novel hormonal therapeutics) will be a promising strategy to enhance tissue
regeneration in numerous pressure patients. This project aims to create stable hormonal therapeutics and study
their therapeutic efficacies alone or with adult adipose stem cells (ASCs) or induced pluripotent stem cells
(iPSCs) to heal chronic PUs. Specific Aims: (Aim 1) Generate novel hormonal therapeutics with potent and
effective bioactivity on keratinocytes and endothelial cells (KECs). (Aim 2) Investigate the effects of novel
hormonal therapeutics on reprogramming of KECs from ASCs or iPSCs in vitro and in rodent models. (Aim 3)
Determine the efficacy of combination regimens (novel hormonal regimens plus ASCs or iPSCs) in improving
PU tissue regeneration using a PU rodent model and conduct toxicity studies. Significance: Our novel therapies
allow us to rapidly test whether they suppress PUs specifically to improve patients with PUs. After this study, we
will identify safe and effective anti-PU regimens ready for preclinical development (e.g., toxicity and PK studies),
which will be addressed during Phase II. We expect this work strongly supports future SBIR Phase II to make
this work to be an effective and first-in-class therapy for PUs.

Public health relevance
Project Narrative Pressure ulcers (PUs) are one of the most poorly understood, relatively underestimated, and least researched complications of diseases or their treatment in the U.S. We have identified novel therapeutic approaches using stable versions of engineered peptide hormones combined with adult tissue stem cells to boost healthy circulation vessel regeneration and alleviate PUs. The proposed novel therapies can potentially mitigate the debilitating and painful effects of the progression of PUs among patients with circulating severe endothelial dysfunction and thus have a high impact on helping those disease survivors with despairing PUs. We expect this work strongly supports Phase II to make this work to be a compelling, nontoxic, worthy, and first-in-class therapy for this poorly addressed disease.